The role of cryptic influenza virus proteins in replication and pathogenesis

ABSTRACT
Productive infections by RNA viruses require faithful replication of full-length genomes. Yet many RNA viruses
also produce deletion-containing viral genomes (DelVGs), aberrant replication products with large internal
deletions. DelVGs interfere with the replication of wild-type virus and their presence in influenza patients is
associated with better clinical outcomes. The DelVG RNA itself is hypothesized to confer this interfering activity.
DelVGs antagonize replication by out-competing the full-length genome or by triggering innate immune
responses. Here, we show this understanding is incomplete. We discovered a new inhibitory mechanism
mediated by a previously unknown class of viral proteins. Specifically, we identified hundreds of cryptic viral
proteins translated from DelVGs. These DelVG-encoded proteins (DPRs) include canonical viral proteins with
large internal deletions, as well as protein truncations with novel C-termini translated from alternative reading
frames. We show that DPRs are common features of influenza virus infections in culture and in humans.
Preliminary results provide strong support and mechanistic data for DPR-mediated interference of wild-type virus
replication. Yet, as we only recently discovered DPRs, we have limited knowledge on the scope and diversity of
DPRs made during infection, the different activities they might possess, and their cumulative impact on disease.
As all RNA viruses make DelVGs, many with the potential to express DPRs, this leaves a large gap in our
knowledge across RNA virology. We address this with three Aims. In Aim 1, we characterize the interference
activity of DPRs we have already discovered and establish their mechanism of action. Aim 2 defines the full
repertoire of DPRs from primary influenza virus isolates, and tests almost all possible DPR types by screening
a synthetic DPR library. Aim 3 then investigates the in vivo inhibition by DPRs and establishes their contribution
to interference activities that suppresses wild-type virus replication and disease. These self-reinforcing Aims will
provide a comprehensive view of DPR formation, mode of action, and impact on infection and pathology.
Moreover, the detailed knowledge gained here will be critical in achieving the long-sought goal of developing
DelVG-containing viruses as antiviral therapeutics.

Public health relevance
PROJECT NARRATIVE The influenza virus polymerase replicates full-length copies of the viral genome, yet replication errors can create genome segments with large internal deletions. Here we show that these deletion-containing viral genomes produce hundreds of cryptic proteins during infection. We study the impact these proteins have on viral replication and disease.